RNA penetrations into bacteria.

Project Summary
Single-stranded RNA bacteriophages (ssRNA phages) are small near-icosahedral viruses that
use RNA as genetic material to infect bacteria through retractile pili. Recently >15,000 new ssRNA
phages have been identified but their hosts and mechanisms of infection remain unknown. Of the
steps during the infection cycle of ssRNA phages, how phages package the genomic RNA and
recognize its specific host are only known for model ssRNA coliphages such as MS2 and Qβ; and
how RNA is ultimately delivered into the cytosol is obscure. From the preliminary data, the PIs
find that the previous paradigm set for the infection mechanism of ssRNA phage based on model
coliphages can no longer be applied to other ssRNA phages.
Host receptors of ssRNA phages, the retractile pili, are usually involved in the virulence of
pathogenic bacteria and the sharing of antibiotic-resistant plasmids. This project will focus on
phages PP7 and AP205, which infect Pseudomonas aeruginosa and Acinetobacter spp.,
respectively, via the Type IV pili (T4P). The overall goal is to determine the mechanisms involved
in PP7/AP205 packaging, and RNA penetration into the host, a process which involves both host
recognition and RNA entry. Specific aims are to reveal the molecular mechanisms for (1) the
packaging of PP7/AP205, (2) the interplay between PP7/AP205 and T4P before RNA entry, and
(3) the detachment of T4P during RNA entry. This work will not only reveal insights into the
infection mechanism of ssRNA phages but also provide guidelines to engineer ssRNA phages for
the following purpose: ssRNA phages will be engineered as means to detach pili of pathogenic
bacteria, as an alternative strategy for treating multidrug-resistant bacterial infections. Unlike
traditional phage therapy by lysing pathogens, virulence and antibiotic resistance spread are
inactivated by breaking pili while leaving the cells to grow, without exerting selective pressure on
the host to develop further resistance. Such a method also avoids the release of any unwanted
cell contents including DNA, proteins, and toxins into the environment which could interfere with
other bacteria or affect human cells. In the future, the proposed project will also provide a basis
for developing a method for packaging and delivery of a large number of foreign RNAs into
bacterial cells. Due to the short life of RNAs inside the cell, they allow transient regulation of the
cells and are less likely to exert long-term genetic effects as in the case of DNA plasmids. In
addition, RNA delivery with ssRNA phages does not rely on the artificial preparation of cells
competent for heat-shock or electroporation, which is hard to perform in situ.

Public health relevance
Project Narrative This project aims to reveal the mechanisms of how single-stranded RNA bacteriophages (ssRNA phages) PP7 and AP205 package their genomic RNA to be delivered to Pseudomonas aeruginosa and Acinetobacter spp., respectively via the Type IV pili, by combining high-resolution cryo-electron microscopy, in-situ fluorescence microscopy, and multi-scale computational modeling. Unlike double-stranded DNA phages, ssRNA phages do not have pressurized capsids or dedicated DNA delivery machinery, and how ssRNA phages package and deliver RNA into the cell remains a mystery. Knowledge gained from this project will provide an alternative strategy for treating multidrug-resistant bacterial infections by specifically cleaving/stalling Type IV pili.